PHARMACOKINETICS OF TRANSFERED VWF IN PATIENTS WITH VW DISEASE

The aim of this project is to test the hypothesis that von Willebrand factor must be present in order for Desmipressin releasable FVIII to be stored in vivo.